Gag Trafficking, Assembly, and Release

While it is clear that HIV-1 assembly occurs predominantly on the plasma membrane (PM), the itinerary that the HIV-1 Gag precursor follows to reach this destination remains ill defined. Likewise, the host cell machinery that promotes Gag trafficking to the PM is incompletely understood. We and others have demonstrated that the matrix (MA) domain of Gag regulates targeting to the site of virus assembly, and we discovered that the phosphoinositide PI(4,5)P2 is a key player in directing Gag to the PM. We hypothesize that host factors in addition to PI(4,5)P2 play a vital role in the trafficking of Gag to the PM. In this project, we are defining the role of host cell machinery in Gag trafficking to the PM and in subsequent steps of particle assembly and release. This effort combines virology, biochemistry, cell biology, and imaging techniques. Our overarching goal is to establish a unified view of the mechanism and pathway(s) involved in the late stages of the HIV-1 replication cycle and to develop inhibitors of HIV-1 Gag trafficking, assembly, and release. ___ Most of our efforts, and those of our colleagues, with regard to late-acting host factors have focused on factors that promote HIV-1 particle assembly and release. However, we have become increasingly interested in cellular factors that interfere with the late stages of HIV-1 replication. The best-characterized example of a late-acting negative factor is tetherin (BST-2), an interferon-stimulated gene product that restricts viral particle release at the cell surface. Tetherin is counteracted by the HIV-1 Vpu protein and the Nef or Env proteins of certain strains of HIV-2 and simian immunodeficiency virus. Apart from tetherin, however, little is known about the host cell factors that interfere with HIV 1 assembly or release. We are engaged in studying these host proteins, with an initial focus on the T-cell immunoglobulin and mucin domain (TIM) family of phosphatidylserine-binding proteins. We recently reported, in collaboration with Dr. Shan-Lu Liu's lab (Ohio State University), that the TIM-family proteins strongly inhibit HIV-1 release by retaining HIV-1 particles on the cell surface through binding to phosphatidylserine on the viral membrane. We will further characterize the mechanism of action by which such host factors restrict HIV-1 particle production, resulting in diminished viral production and replication. We have been involved with studies examining the effect of the host factor PSGL-1 on the binding of virus particles to target cells and the incorporation of viral envelope glycoproteins into virions. We are also examining the role of neutral sphingomyelinase 2 on HIV assembly, release, and maturation. Finally, we have several major projects focused on the role of the small cellular polyanion inositol hexkisphosphate (IP6) in HIV-1 assembly and maturation.